Cancer Control and Population Science (CCPS)

The Cancer Control and Population Sciences (CCPS) Program is a realigned, unified program of the former
Cancer Epidemiology and Prevention and Health Behavior and Outcomes programs. CCPS members pursue
research in epidemiology, prevention and occurrence reduction, behavioral interventions, cancer care delivery,
and methods development, along with implementation science and policy research. CCPS’s aims and
strengths are closely aligned with the Rogel Cancer Center’s broad- based themes, strategic vision, and
mission via the program’s focus on team science, its commitment to understanding cancer etiology, improving
primary prevention and early detection strategies, and improving cancer care delivery. The CCPS program has
three main specific aims: 1) Identify key environmental, lifestyle, genetic, and socio-structural targets for cancer
prevention, risk reduction, improved detection, and better outcomes; 2) Develop, test, and deploy innovative
strategies to reduce the burden of cancer; and 3) Create and apply novel scientific approaches to cancer
control and population science research across the continuum.